Project 1 - Effects of Bilateral Oophorectomy on Physical and Cognitive Aging

PROJECT 1: SUMMARY/ABSTRACT Michelle M. Mielke, Ph.D.
Hysterectomy is the second most common major surgical procedure performed among women living in the
United States after cesarean section. Among women who undergo hysterectomy, 23% aged 40-44 years and
45% aged 45-49 years undergo bilateral salpingo-oophorectomy (BSO) at the same time to prevent ovarian
cancer. Although premenopausal BSO is associated with a significant reduced risk of ovarian and breast
cancer, there is increasing concern that BSO may have harmful long-term effects which can negate some of
the benefits conferred by protection from cancer. Ovaries are both endocrine and reproductive organs. They
secrete hormones before menopause (primarily estrogen, progesterone, and testosterone) and after (primarily
testosterone, androstenedione, and dehydroepiandrosterone). Thus, reduced ovarian function, especially as
caused by the removal of ovaries, can impact multiple systems throughout the lifespan. Prior to menopause,
ovarian removal causes significant endocrine disruption. The practice of prophylactic BSO is now declining.
However, given the large number of women who have undergone abrupt endocrine disruption by
premenopausal BSO over the past decades, there is an urgent need to understand the impact on long-term
physical and cognitive function. In addition, elucidating the underlying biological mechanisms may help to delay
or prevent the potential negative consequences of premenopausal BSO as these women age. The overall aim
of Project 1 is to better understand the long-term functional and cognitive effects and the potential
underlying mechanisms resulting from abrupt premenopausal endocrine dysfunction. Recent studies
suggest that premenopausal BSO may be associated with accelerated aging. However, the underlying
biological mechanisms have not been examined, other than DNA methylation. In addition, it is not clear
whether the endocrine disruption that results from premenopausal BSO has a global effect on all physical and
cognitive functions, or whether specific domains of physical or cognitive function are more affected than others.
We hypothesize that the abrupt and significant endocrine disruption caused by premenopausal BSO will
contribute to accelerated aging, as measured by a greater decline in physical and cognitive function and by
higher plasma levels of senescence associated secretory phenotype (SASP) proteins compared to referents.
To test these hypotheses, we will utilize an established and well-characterized population-based cohort of
women with and without premenopausal BSO, who are now only passively followed through the Rochester
Epidemiology Project medical-records linkage system. We will recruit, for an in-person study, 250 women with
and 250 women without premenopausal BSO a median of 22 years after their surgery or index date. We will
extensively characterize their physical and cognitive function and collect blood samples to measure SASP
proteins, a novel marker of aging. Studying women who underwent BSO in the past decades provides a unique
natural experiment to understand the effects of endocrine function in regulating the pace of aging.

Public health relevance
PROJECT 1: NARRATIVE Michelle M. Mielke, Ph.D. It is estimated that one in eight women have their ovaries removed before reaching natural menopause, which results in an abrupt and significant endocrine disruption. We propose to study the effects of premenopausal bilateral salpingo-oophorectomy (BSO) on the pace of aging measured by declines in physical and cognitive function and by a new blood-based biomarker of accelerated aging. Our ultimate goal is to understand the effects of abrupt endocrine disruption on multimoribidity and aging, and to guide future preventive interventions to slow aging in women who have undergone BSO.